CORE C: DMSC Core

SUMMARY/ABSTRACT
Data Management and Statistics Core (DMSC)
The Data Management and Statistics Core (DMSC) is an integral component of the Center for
Neurodegeneration and Translational Neuroscience (CNTN), providing each project and core with the digital
infrastructure for accurate data capture, secure storage, access to high-quality integrated datasets, and expert
statistical consultation. Through these resources, the DMSC directly facilitates the CNTN goals of advancing the
careers of junior investigators, expanding the neuroscience and research infrastructure in Nevada, and
enhancing the understanding of neurodegenerative diseases (NDD). In Phase 1 of the COBRE award, the
DMSC adopted OpenClinica, an open-sourced electronic data capture platform, to construct a distributed cloud-
based data entry system that is 21 CFR Part 11 compliant. Throughout Phase 1, the Clinical and Translational
Research Core (CTRC) of the CNTN established a cohort of individuals with AD or PD, and a group of
demographically comparable cognitively normal (CN) older adults. A comprehensive data set generated by the
CTRC, captured using OpenClinica, and maintained by the DMSC serves as a gateway for NDD researchers
and collaborators who are not project leaders. Given the growth of the DMSC under the leadership of Joseph
Lombardo in Phase 1, we intend to expand this Core during Phase 2. Director Lombardo will continue to lead
the Core. Guogen Shan, PhD will serve as Associate Director for Biostatistics and will continue to work with
COBRE and non-COBRE researchers to develop novel statistical tools to analyze neuroscience data. Justin B.
Miller, PhD, a neuropsychologist with a deep interest in biomedical informatics, will be the Associate Director for
Biomedical Informatics for Phase 2. During Phase 1 of the award, Dr. Miller worked under the mentorship of
Gustavo Jiminez-Maggoria, Director of Informatics at the University of Southern California’s Alzheimer’s
Therapeutic Research Institute, and has functioned as a liaison between DMSC faculty, the CTRC, and project
leaders to ensure that the database functions smoothly for comprehensive data capture, organization, archiving,
analysis, and export to non-COBRE research communities. In Phase 2 of the award, Dr. Miller will continue to
work with project leaders and core directors to ensure that study data are of good quality, readily available, and
accessible to project leaders. Additionally, in Phase 2, members of the DMSC will work extensively with the
newly formed and recently integrated Brain Imaging Core (BIC). Phase 2 will require expansion and refinement
of the DMSC’s digital infrastructure to facilitate integration of both raw image data and structured quantitative
imaging data.

Public health relevance
NARRATIVE Data Management and Statistics Core (DMSC) Derivation of novel insights and new knowledge is predicated on sound data management practices that allow for reliable validation and replication of results, thereby permitting new and innovative research to be built on existing information and providing a basis for training early investigators in practical data analysis and management. Consistent with the primary aims of the Center for Neurodegeneration and Translational Neuroscience (CNTN), the Data Management and Statistical Core seeks to advance the scientific process and the goals of the CNTN by providing content expertise in data science, informatics, and statistics, as well as, low- friction information technology solutions for managing, analyzing, extracting knowledge, and sharing research data. These functions are essential in order for the full value of public investment in research to be realized.